Investigational New Drug (IND)-enabling Study for a New Therapeutic for Alcohol Use Disorder (AUD)

Summary.
While the stress response is essential for survival, it can become dysregulated. Overactivation of the
hypothalamic-pituitary-adrenal (HPA) axis plays a mechanistic role in the pathophysiology of alcohol
use disorder (AUD). This SBIR Phase I proposal in response to PAR-22-102 is aimed at initiating
Investigational New Drug (IND)-enabling studies for an innovative first-in-class therapeutic aimed at
the chronic management of pathologic HPA axis hyperactivity for the treatment of AUD. Evidence
indicates that preventing excessive HPA activation in the setting of AUD will restore HPA negative
feedback and reset the system at more physiological levels, reducing motivation for drinking and
relapse. Therapeutics to modulate the HPA axis have been under research for decades. Several
medications for HPA axis hyperactivity have been studied extensively but have generally been
unsatisfactory due to limited efficacy on the HPA and side effects. Thus, there is a considerable
unmet medical need for identification of novel therapeutics to normalize HPA hyperactivity that are
effective and tolerable for long-term use. This Phase I SBIR will manufacture and validate the test
article for Investigational New Drug (IND)-enabling studies and initiate IND-enabling studies including
the development and validation of a UV-VIS method for the determination of test material
concentration in dose formulations; development and validation of an enzyme-linked immunosorbent
assay (ELISA) method for the quantification of test material in serum; and will carry out single-dose
intravenous bolus injection pharmacokinetic and tolerability studies in two species. These activities
will lay the foundations for the completion of IND-enabling studies and IND submission in the eventual
Phase II of this SBIR.

Public health relevance
Narrative. Hypothalamic pituitary adrenal axis (HPA) hyperactivity contributes to the pathogenesis of alcohol use disorder (AUD) as well as other conditions that contribute to or have detrimental interactions with AUD such as depression. The present SBIR seeks to carry out Investigational New Drug (IND)- enabling studies for an innovative first-in-class therapeutic aimed at reducing HPA hyperactivity for the long-term management of AUD.